Supplement to R01 NS124477

Abstract
We request an Administrative Supplement to our NINDS-funded grant R01 NS124477 ‘Novel pathogenic
mechanism of HIV-associated CNS neurological disorders’ to fund a postdoctoral position for a Ukrainian
scientist, Dr. Daria Starosyla. She will take over a new research direction in the project funded by the parent
grant, investigation of the role that trained immunity plays in the neuroinflammation underlying pathogenesis of
HAND. Our recent discoveries suggested a possibility that neuroinflammation is ‘imprinted’ in brain myeloid and
glial cells by exposure to extracellular vesicles carrying HIV-1 protein Nef. So far, we have demonstrated this
effect in peripheral blood and bone marrow myeloid cells, and the foray into the brain cells will be a novel
development in neurobiology and contribute significantly to all Specific Aims of the parent grant. Given Dr.
Starosyla’s experience in immunology, virology and development of anti-viral treatments, we believe she is well
fit to take over the leading role on this part of the project. In addition to scientific reasons behind this request for
Supplemental Funding, it also carries a humanitarian and political significance. The ongoing war in Ukraine
severely affects all scientific enterprises in the country and endangers not only the present, but also the future
scientific progress in Ukraine. It is critical to provide support and training to Ukrainian scientists during this tragic
period in the history of their country, so that when the war ends, they can return to Ukraine ready to rebuild
scientific programs. The training provided to Dr. Starosyla will prepare her for a future research career in the
overlap of neurobiology and virology.

Public health relevance
Project Narrative We request an Administrative Supplement to our NINDS-funded grant to fund a postdoctoral position for a Ukrainian scientist, Dr. Daria Starosyla. She will investigate the role that trained immunity, a recently discovered phenomenon where HIV induces long-lived hyperreactivity of innate immune cells, plays in the neuroinflammation underlying pathogenesis of HAND. Dr. Starosyla’s experience in immunology and virology makes her a good candidate for this project. In addition, this funding will provide support for a Ukrainian scientist at the time of distress due to ongoing war in Ukraine.